Clinical Research Education in Genome Science (CREiGS)

Project Summary/Abstract
The sensitivity and availability of omic technologies have enabled the genomic, transcriptomic
and proteomic characterization of disease phenotypes, at the tissue and even the single cell level. This has
allowed development of treatments that target specific disease subtypes, most notably in cancer
treatment, and thus opened up opportunities for the development of precision/personalized medicine
strategies for optimizing treatments for individual patients. Thus, new genomic science educational initiatives
need to be continually updated to educate the clinical and translational workforce on how to effectively
interpret and apply the findings from genomics studies. Patients of providers who have participated in these
educational initiatives also benefit as it allows for more rapid integration of genomic study findings into the
clinical care setting. Thus, in response to PAR-19-185, we propose to develop and implement the
Clinical Research Education in Genome Science (CREiGS) program that will not only focus on the
analysis of genomic data, but also on gene-expression data, the integration of these two data types, as well
as introductory theory and application of statistical and machine learning methods. Specifically we
propose to accomplish the following specific aims:
1. Develop and successfully implement the online and in-person phases of CREiGS to increase the
methodologic ingenuity by which researchers tackle important genomics-related clinical problems.
2. Establish a Diversity Recruitment External Advisory Board to ensure that the most effective strategies
are employed to recruit URM doctoral students, postdoctoral fellows, and faculty from academic institutions
nationwide into CREiGS.
3. Enhance the dissemination phase of CREiGS by packaging and uploading the asynchronous lectures
and the online critical thinking/problem solving assessments with solutions for publicly available, online
teaching resources.
4. Implement effective methods to evaluate the efficacy of CREiGS by examining:1) the participants' grasp
of the CREiGS core competencies, 2) the clarity and quality of the curriculum, 3) program logistics and
operation, and 4) the participants' short-term and long-term success attributed to participation in CREiGS.
In summary, we posit that CREiGS will provide participants with a solid foundation in genomics science to
answer complex, clinical questions. We believe that CREiGS supports the mission of the NHGRI by providing
researchers with rigorous training to “accelerate medical breakthroughs that improve human health.”

Public health relevance
Project Narrative The sensitivity and availability of omic technologies have allowed for the development of treatments that target specific disease subtypes, most notably in cancer treatment, and thus opened up opportunities for the development of precision/personalized medicine strategies for optimizing treatments for individual patients. Thus, new genomic science educational initiatives need to be continually updated to educate the clinical and translational workforce on how to effectively interpret and apply the findings from genomics studies. The overall goal of the Clinical Research Education in Genome Science program is to increase the methodologic ingenuity of students, postdoctoral fellows, and faculty from academic institutions nationwide through a solid foundation in genomics science to answer complex, clinical research questions and improve patient care.